Dissecting mechanisms of inflammation driven cancer susceptibility in epithelial barrier tissues

Project Summary/Abstract:
Inflammation has long been known to increase risk of tumorigenesis. Epithelial barrier tissues are
perpetually exposed to a myriad of environmental and inflammatory insults that necessitates robust regenerative
capacity of their tissue-specific epithelial stem cells (EpSCs) to restore barrier integrity. The long term
consequences of these inflammatory encounters on the tissue and EpSCs is poorly understood. Here, I seek to
understand how exposure to inflammation results in epigenetic and cellular rewiring of EpSCs and their lineages
in different barrier tissues and how this rewiring can be maladaptive leading to increased cancer susceptibility.
The F99 phase of this proposal is focused on the mechanisms by which inflammatory experience is
encoded within the chromatin of skin epithelial stem cells (EpSCs) and how inflammation-experienced skin
accelerates tumor formation. I have begun to uncover the molecular mechanisms of how EpSCs acquire and
maintain chromatin accessibility at key domains associated with stress response genes that contribute to an
inflammatory response. My studies suggest that this phenomenon occurs through the complex and dynamic
interplay between transcription factors (TFs) that are naturally present in steady state EpSCs but cannot gain
access to stress response enhancers without inflammation-induced TFs. As I unearth the molecular mechanisms
involved, I will interrogate how this inflammatory rewiring of skin EpSCs epigenome accelerates tumor formation
as EpSCs acquire oncogenic mutations that lead to squamous cell carcinomas (SCCs), a life-threatening,
metastatic cancer for which there are few effective therapies. At the completion of the F99 phase, l will have
gained strong experience in in vivo high-throughput epigenetics, mouse genetics and epithelial stem cell biology,
and transition to a postdoc to gain advanced expertise and training in human cancer and immunology.
For the K00 phase, I will shift my focus to how inflammatory experience can reshape colonic epithelium
composition in the gut and how this reshaping, along with EpSC epigenetic rewiring, results in colorectal cancer
(CRC). Interestingly, colitis can result in colitis-induced CRC that follows a different molecular driven
pathogenesis than traditional CRC. Thus, to further understand the mechanisms that drive colitis-induced CRC,
I plan to expand my technical expertise to include colitis-induced CRC modeling, single-cell epigenomic and
transcriptomic techniques, genetic screening and human organoid modeling. These new approaches coupled
with my already strong background in molecular biology and high-throughput genomic analyses, will allow me to
address the most pressing and challenging issues in inflammation experience and cancer biology today. With
the aid of this award, I intend to continue my research contribution and gain the necessary experience to become
an Assistant Professor at a major academic institution. There I will head my own lab and guide my students in
epithelial cancer research with the ultimate goal of finding new targets to treat these aggressive cancers.

Public health relevance
Project Narrative: The body’s epithelial barriers are routinely subjected to inflammatory stressors, necessitating robust regenerative potential to sustain barrier integrity. Following recurrent exposures to inflammatory stressors, tissues and their stem cells become increasingly susceptible to cancer formation. The proposed research will evaluate the long term effects that inflammation has on barrier tissues and how these effects lead to epigenetic rewiring in stem cell populations that results in cancer susceptibility and tumor formation.